Project 4: Inhibiting Novel Autophagy Mediator ATG4B for Treating Glioblastoma

PROJECT 4: PROJECT SUMMARY
Enhancing GBM Cytotoxic Therapy Through Inhibition of Key Autophagy Mediator ATG4B
Glioblastoma (GBM) is the most common and malignant primary brain tumor. Despite treatment consisting of
surgical removal, radiation and chemotherapy, most patients with GBM die within 14 to 16 months after
diagnosis, underscoring the urgent need for new therapies to combat this deadly disease. Autophagy is a
conserved catabolic process that maintains homeostasis by regulating the energy balance of the cell. Cancer
cells use autophagy to remove damaged organelles and aggregated proteins, and to recycle nutrients in high
demand to support tumor growth. Radiochemotherapy (RT-TMZ) is the front-line treatments against GBM, but
also activate the autophagic response in tumor cells, thus protecting the cells from undergoing apoptosis.
Inhibition of mTOR signaling is a common target in cancer therapy. However, mTOR inhibition also induces
autophagy in cancer cells. Consequently, there is immense interest in inhibiting this protective mechanism while
treating cancer. Non-specific autophagy inhibitors like chloroquine (CQ) and hydroxy-CQ (HCQ) are being
investigated in a large number of clinical trials. However, the lack of specificity of these compounds is ,
associated with toxicity and may diminish its efficacy. We discovered that ATG4B, an enzyme that converts LC3
to LC3-I/II, which is required for autophagy process in cells, is phosphorylated at serine residue 383 (p-S383)
in patient-derived glioma stem-like cells (glioma initiating cells or GICs). We also found that ATG4B S383
phosphorylation increases GIC autophagic activity, and that intratumoral expression of p-S383 ATG4B
correlates with poor prognosis in GBM patients. In contrast, knockdown of ATG4B, or expression of a non-
phosphorylatable ATG4B mutant transgene (S383A), inhibits GSC autophagic response and tumorigenicity
when engrafted in the brains of athymic mice. Furthermore, pharmacologic inhibition of ATG4B, using a NCI
compound NSC185058 that inhibits ATG4B enzymatic activity and GBM tumorigenicity, markedly enhanced RT
inhibition on GBM tumor growth and increases the survival of animals with intracranially engrafted GIC.
Additionally, NSC185058 also markedly enhanced inhibitory effects by a catalytic mTORC inhibitor AZD2014
on GICs. Based on these strong data and our established multiple PDX GBM models of distinct genetic +
epigenetic profiles, in this project, we propose to determine the anti-GBM efficacy of ATG4B inhibitor
NSC185058, as monotherapy and in combination with RT-TMZ; investigate the therapeutic potential of
combining inhibition of ATG4B, mTOR and RT and develop NSC185058 for use in patients, and test the ATG4B
inhibitor, both as a single agent and in combination with cytotoxic therapy, in a clinical trial for treating patients
with recurrent GBM. This project has a strong molecular mechanistic foundation and associated therapeutic
hypothesis that, if proven correct, has the potential for positive impact on the treatment of GBM, and perhaps
other malignancies.

Public health relevance
PROJECT 4: NARRATIVE Enhancing GBM Cytotoxic Therapy Through Inhibition of Key Autophagy Mediator ATG4B In malignant glioblastoma (GBM), autophagy-mediated intracellular recycling sustains tumor metabolism, growth and survival favors tumor growth and progression. Autophagy in response to therapeutic treatments such as radiation and chemotherapies also provides a mechanism for GBM cell to survive and acquire resistance to therapies. This application will test hypotheses that activation of ATG4B is a critical step in a compensatory autophagic response that GBM employ when confronted with cytotoxic therapy, and that inhibiting ATG4B/autophagy activities with a novel inhibitor NSC185058 will enhance the anti-glioma effects of RT-TMZ and inhibition of mTOR activities in preclinical and clinical studies.